A framework for feasible translation to enhance foot and ankle function in aging and mobility

PROJECT SUMMARY / ABSTRACT
This supplement will support Ms. Paula Kramer, a doctoral student from an underrepresented minority, to
examine how new and modifiable targets to enhance mobility and restore independence affect balance and
stability in our rapidly aging population. The specific objective of the research is to examine the role of foot and
insole stiffness on gait stability in older adults. By extending the parent grant to examine measures of gait
stability, this proposal explores how manipulations of foot-insole stiffness affect the stability of walking; this
research complements and extends the mechanical power calculations described in the parent grant. This
research objective is embedded within training and career development objectives that allow Ms. Kramer to
explore biomechanical research in a collaborative and multi-institutional environment supported by the parent
grant spanning the University of Utah and the University of North Carolina – Chapel Hill. Ms. Kramer’s current
career stage enables maximum impact for the proposed supplement; she will benefit from multiple mentors
early in her graduate research career and develop skills and expertise to compete for future fellowships during
her doctoral studies. The proposed project is tailored to build off Ms. Kramer’s background in neuromechanics
and interest in understanding human movement while providing training in biomechanical considerations,
including joint mechanics and mechanical stability, during walking.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This project introduces and investigates the scientific premise that age-related reductions in walking performance and economy have been mistakenly attributed solely to muscles spanning the ankle, and instead originate interdependently with unfavorable changes in the active, passive, and structural regulation of foot stiffness and power. Accordingly, the translational purpose of this proposal is to test the efficacy of shoe stiffness modifications to augment foot structure and function in aging and thereby improve gait performance and reduce metabolic energy cost during walking in older adults. Ultimately, this project addresses the need for new and modifiable targets to enhance mobility and independence – paving the way for feasible and cost-effective assistive devices for millions in our aging population.